Evaluating VA Patient Centered Care: Patient, Provider, and Organizational Views

Background: Over 40 years ago Balint described patient-centered medicine as "understanding the patient as
a unique human being." By the end of the 20th century, patient-centered care (PCC) became a focus of
contemporary health care systems. Although the term encompasses multiple foci, most providers,
policymakers and researchers agree that PCC represents a shift from traditional, paternalistic, provider-driven,
disease-focused approaches towards health care systems that ensure the patient-including his or her
attitudes, perceptions, needs, and experiences-is fully integrated into every phase of medical consultation,
treatment and follow-up. With the establishment of the Office of Patient-Centered Care and Cultural
Transformation (OPCC&CT), VHA has demonstrated its commitment to providing the most patient-centered
care possible to our nation's veterans, as an ethical imperative and as a critical element of improving patient
care and outcomes. Many of these interventions to improve patient-centered care have are designed based on
PCC principles are currently being implemented by the OPCC&CT Centers of Innovation, but how they achieve
the goals of PCC remains unknown.
Objectives: The goal of this project is to evaluate the experience and practice of PCC at three established
OPCC&CT Centers of Innovation (COI), using our team's extensive experience in evaluating patient-centered
care, communication, eHealth technologies, integrative therapies and organizational context. The objectives of
this evaluation project are:
1) To ascertain the extent to which novel approaches to patient-centered care being implemented in the COIs
achieve the goals of PCC. This objective focuses on the "experience" of care from the patient perspective, and
the "practice" of care.
2) To analyze the strategies for implementing the PCC initiatives, the provider responses to them, and the
organizational factors affecting the initiatives.
We will focus our evaluations on four specific aims related to patient-centered care:
Aim 1) To examine the extent to which programs and initiatives implemented at the three COIs are meeting
their stated objectives and the goals of PCC.
Aim 2) To evaluate the effectiveness of available services and innovation initiatives on meeting patient-
centered care goals as outlined in our conceptual model. We focus here on two initiatives: health coaching and
complementary and integrative therapies.
Aim 3) To determine how organizational structures and processes facilitate or hinder the implementation of
PCC initiatives and the development of PCC. We will examine this at all levels of the organization at each
VHA.
Aim 4) To identify how COIs' PCC initiatives utilize eHealth technologies to facilitate patient-centered care.
How do sites capitalize on the use of these technologies for HC or PHP?
Methods: We propose to complete 5 tasks to address these aims, using a combination of survey, existing VA
data sources, qualitative and quantitative methods. We will conduct patient surveys regarding perceptions of
care and outcomes, and conduct site visits including qualitative interviews and observation. We will include
patients who are participating in or exposed to different innovations and initiatives, staff who are involved in
implementing these initiatives and other administrative level key stakeholders. We will utilize existing
OPCC&CT data SHEP data and AES and PCMM data to evaluate the impact of the innovations on key
provider and patient outcomes.

Public health relevance
The Office of Patient Centered Care and Cultural Transformation has brought patient-centered care (PCC) into the forefront of changes in care for Veterans. PCC represents a shift from traditional, paternalistic, provider- driven, disease-focused approaches towards health care systems that ensure the patient-including his or her attitudes, perceptions, needs, desires and experiences-is fully integrated into every phase of medical consultation, treatment and follow-up. The funding of Centers of Innovation for PCC is a first step in a global transformation of care in VA. In this evaluation of the COIs we seek to understand how these transformations are occurring, what types of organizational and practice based barriers or facilitators exist to this shift and ultimately, how these transformations are affecting patients.